iC9-CAR.CSPG4 CAR-T Cells for Head and Neck Squamous Cell Carcinoma

PROJECT SUMMARY AND ABSTRACT
Following treatment with platinum-doublet cytotoxic chemotherapy and a PD1 inhibitor, treatment
options for recurrent/metastatic (incurable) HNSCC are limited in efficacy. CSPG4 is a cell
surface proteoglycan that we and others have shown to be highly overexpressed in HNSCC. We
developed a CAR-T encoding the CD28 endodomain and have shown in vitro and in vivo activity.
We now propose to conduct a phase I, single center, open-label study in adult patients with
HNSCC that is platinum and PD1 refractory. We propose a modified 3+3 design with doses of 5
× 105, 1 x 106 and 5 x 106 cells followed by a dose expansion cohort of 9 more patients at dose
to better characterize safety, to provide pilot data on efficacy, and to provide samples for
correlative analysis. To fully characterize the impact of CAR-T on both tumors and T cells, we will
collect pre- and post- treatment biopsies as well as serial blood samples. We will model changes
in both the CAR-T cells and non-CAR T cells through qPCR, flow cytometry for markers of
exhaustion (CD57, PD1, LAG-3), metabolomic profile, and stemness. We will utilize TCR-seq to
demonstrate the clonality of non-CAR T cells in tumor, comparing pre-treatment biopsy to post-
treatment biopsy as well as to blood at serial time points. Further, we seek to study how to
overcome tumor escape mediated by heterogeneity in CSPG4 expression. We have reported a
bystander mechanism of tumor killing by CAR-Ts associated with CD95 expression in tumor cells
and Fas-L expression by activated CAR-Ts and observed that TNFα released by CSPG4.CAR-Ts
upon antigen engagement induces the upregulation of CSPG4 in tumor cells. We will assess
CSPG4, CD95 and TNFα expression and co-localization. Finally, we will discover the extent to
which iC9.CSPG4.CAR-T cell therapy induces epitope spreading in treated patients, including
analysis of T cell responses to the full landscape of HPV antigens and neoantigens. This will both
increase our understanding of mechanisms of CAR-T efficacy and provide rationale for
combination of CAR-T therapy with T cell antigen-directed therapy (e.g. therapeutic neoantigen
vaccination and/or TCR-T therapy).

Public health relevance
PROJECT NARRATIVE Adoptive T cell therapy to treat liquid malignancies has been revolutionized by the use of chimeric antigen receptor (CAR) T cell in the past decade, but the success of this approach has been challenging to replicate for solid tumors such as squamous head and neck cancer. We seek to demonstrate the safety and efficacy of CAR-T against CSPG4 in squamous head and neck cancer. We further seek comprehensive characterization of both target and non-target mechanisms of efficacy and resistance to define the next clinical steps.